Libre Del Cigarrillo: Development of an mHealth Smoking Cessation App to Extend Reach of a Validated Smoking Cessation Intervention for Spanish-speaking Smokers

Project Summary
Racial/ethnic minorities suffer disproportionately from smoking related morbidity and mortality. Four of
the five leading causes of death among Hispanic/Latinx (hereafter referred to as Hispanic) individuals are
smoking-related; thus, there is a significant public health need to reduce smoking in this population. Despite
the Hispanic population being the largest and one of the fastest growing minority populations, there is a dearth
of culturally appropriate Spanish-language smoking cessation interventions. Previous work from our research
group and others has demonstrated unique barriers faced by Hispanic smokers, such as less access to
cessation treatments and overall less utilization of evidence-based cessation treatments. To address the gap in
availability of Spanish-language interventions, our team used a multi-step process to develop a printed self-
help smoking cessation intervention for Hispanic smokers, “Libre del cigarrillo, por mi familia y por mí: Guía
para dejar de fumar” (LDC; “Free from cigarettes, for my family and for me: Guide to quitting smoking”).
Findings from our randomized controlled trial (RCT) with a nationwide sample (N=1,417), revealed high
efficacy of our intervention through 24 months compared to Usual Care (an NCI-produced Spanish-language
self-help booklet). There are, however, key limitations with the print modality, including the inability to access
intervention content in real time and limited ability to enhance engagement with the intervention content. Given
the increasing popularity of digital interventions and high ownership of smartphones among Hispanics (91%) a
smartphone app delivering evidence-based smoking cessation content can overcome these barriers and has
additional strengths. The goals of this study are to adapt our validated printed smoking cessation intervention
for Spanish-speaking smokers into a smartphone app (Aim 1) and to conduct a three-arm pilot RCT to examine
feasibility and acceptability of the smartphone app intervention and feasibility of the future clinical trial (Aim 2).
The smartphone app version will be based on our recent formative research, bidirectional stakeholder
engagement, and validated content that we have already transcreated and will be enhanced via functionality of
the app (Aim 1). After the Libre del Cigarrillo smartphone App is developed (Aim 1), participants (N=120) will
be randomly assigned to either the: (1) newly developed Libre del Cigarrillo smartphone app; (2) existing Libre
del Cigarrillo booklets; or (3) NCI smokefree TXT (text) program in Spanish (standard-of-care-comparator)
(Aim 2). We will evaluate feasibility and acceptability of the smartphone app and future clinical trial feasibility
using a priori benchmarks. We will also measure changes in intermediary smoking-related variables (e.g.,
motivation, self-efficacy) and smoking behavior. This R34 represents the next logical step in a systematic
approach to develop scalable, cost-effective, and accessible smoking cessation interventions for Spanish-
speaking individuals who smoke. This work has potential to expand dissemination of smoking cessation
interventions to an underserved population, and ultimately reduce tobacco-related health disparities.

Public health relevance
Project Narrative Research is needed to develop scalable and cost-effective interventions for Spanish-speaking smokers. The aims of this study are to adapt a validated smoking cessation intervention for Spanish-speaking smokers into a smartphone app modality using existing evidence-based, culturally appropriate intervention content and to examine feasibility and acceptability of the smartphone app intervention. Efforts aimed at promoting tobacco abstinence among this underserved population could have significant public health implications, including the potential reduction of ethnic health disparities associated with tobacco smoking.